Mechanisms and Control of Thalamocortical Synchrony in Absence Epilepsy

Project Summary
The foundation of epilepsy diagnosis and patient-tailored treatment strategies relies on the detection of
stereotyped patterns in EEG recordings. These patterns require synchronous brain activity because electrical
signals are additive, and thus peaks and troughs cancel when misaligned. Despite this connection, the role of
neuronal synchrony in epilepsy mechanisms is surprisingly unclear. I am seeking to test for the presence and
origin of widespread neuronal synchronization in absence epilepsy and test if it has a causal role in absence
seizure generation. Absence seizures have an abrupt onset of bilaterally synchronous spike wave discharge
(SWD) EEG pattern across widespread areas of the brain. These seizures depend on both cortical and
thalamic networks but we do not know to what degree widespread cortical and thalamic synchronous firing
occurs, which brain structures are involved, or if there is any direct causal role of synchronization between
cortex and thalamus in absence seizure generation or maintenance. A fundamental principle for understanding
synchronization between network nodes is the following: the greater the similarity between the two nodes in
oscillation frequencies, the more readily they synchronize. My central hypothesis is that coordinated changes
in firing rates to a common frequency promotes corticothalamic synchronization, generating seizures. In aim 1 I
seek to measure and perturb firing rates to test whether firing rate convergences to a common rate directly
promote their synchronization. I will use multiple high density silicon probes to measure the population firing
rates of various target brain areas in the cortex and thalamus in the times leading up to and during absence
seizures. Subsequently, using chemogenetics, I will force a subset of neurons within a given target region to
fire at an incompatible firing frequency, which I predict will preclude its recruitment into this otherwise globally
synchronous firing during a seizure. In aim 2, I seek to test for a causal role of corticothalamic synchronization
in absence seizures. I will initiate seizures optogenetically with halorhodopsin induced rebound firing in
thalamocortical neurons as has been done previously, and then use closed loop activation of channelrhodopsin
expressed in the corresponding corticothalamic input axons. This will provide cortical input to the thalamus at
defined phases and frequencies relative to the SWDs, testing whether cortical synchronization and/or specific
relative frequencies with thalamus regulates seizure induction or duration. This work will for the first time
demonstrate both the widespread presence of synchronous neuronal firing and a causal role of corticothalamic
synchronization in absence seizure generation. This project will be performed under the guidance of two
mentors, Dr. Huguenard guiding training in experimental aspects and Dr. Ganguli guiding theoretical,
computational, and analysis techniques. With this combined approach along with extensive institution and
professional support at Stanford, I will develop a highly unique skillset with which to begin my own laboratory.

Public health relevance
Project Narrative Patients with absence epilepsy have sudden impairments to their behavior and consciousness that involves the coordinated activity of millions neurons. Here I will measure and manipulate the communication of subsets of these neurons in epileptic mice to understand how such coordination is achieved. This will provide valuable information on how we may disrupt this coordination and improve treatments for this and other forms of epilepsy.